Role of the Chromosome 19 MicroRNA Cluster in Liver Cancers

Project Summary
The chromosomal 19 microRNA cluster (C19MC) is a regulatory part of the genome normally only active
during embryological development and in the placenta. Recently, Dr. Brohl has led work showing that
extreme overexpression of C19MC is a genomic hallmark of a rare cancer, undifferentiated embryonic
sarcoma of the liver [UESL] (Setty BA… Brohl AS, PLOS genetics, 2020). Further, he has shown that C19MC
overexpression is frequent amongst most common adult cancers and that overexpression is linked to
important phenotypic changes. Consistently across cancer types, for example in breast cancer (Jinesh
GG…Brohl AS, PLOS One, 2018) and hepatocellular carcinoma [HCC] (Jinesh GG…Brohl, AS, Scientific
Reports, 2020), C19MC is linked to an undifferentiated status, stem-like features, and therapy resistance.
In this proposal, Dr. Brohl aims to further investigate the role of C19MC in liver cancers, including both
HCC and UESL. In parallel study of the same molecular feature in both a rare tumor and common cancer will
allow him to utilize the advantages of both: genomic and phenotypic uniformity of the rare cancer will enhance
the ability to isolate the effects of the genomic feature of interest, diversity and availability of numerous model
systems of the common cancer will facilitate study of replicability and evaluation of the scope of findings.
Importantly, Dr. Brohl will generate new models, including CRISP/Cas9 knockdown and induction of C19MC
expression that will be valuable for the scientific community not only for cancer biology but for anyone
interested in the study of C19MC (e.g. placental research).
Dr. Brohl is well positioned to lead this proposal. He has already established himself as a clinical expert in
the care of patients with rare tumors, has a robust record of translational genomics research, and has been
principally responsible for the preliminary scientific findings supporting this work. He will be primarily
mentored by Dr. Elsa Flores, a well-funded senior scientist who has substantial experience and expertise in
molecular oncology and non-coding RNA biology. The wet-laboratory component of this proposal will be
conducted in shared space from her lab and with her direct input. The proposal includes a career
development plan and research plan that will provide Dr. Brohl with the expertise and data necessary to
reach his goal of becoming an independent physician-scientist. In addition to Dr. Flores, his mentorship
and advisory team includes Dr. Damon Reed, a senior clinical and translational researcher with expertise in
adolescent and young adult cancers, and Dr. Richard Kim, a clinical researcher and thought leader in the
treatment of hepatocellular carcinoma. Upon completion of this proposal, Dr. Brohl will be well positioned to
transition to research independence. He plans to submit an R01 during the penultimate year of this award
based on the results generated from this work.

Public health relevance
PROJECT NARRATIVE Recently the Brohl lab has led work showing that a regulatory part of the genome called the chromosome 19 microRNA cluster (19MC) is crucially important to the development of a rare cancer and is also commonly affected in many common cancer types. I will perform further study to investigate the role of C19MC in human malignancies by studying it in liver cancers, an area in dire need of therapeutic advances. The study design entails parallel study in both a common and rare cancer type, synergizing the advantages of each.